GUIDE TO SUBSTANCE ABUSE &MENTAL HEALTH WEBSITES

This SBIR last-track application proposes to develop, evaluate, and implement a unique Web-based guide for Internet browsers seeking quality substance abuse and mental health (SA/MH) websites. The site will direct health information seekers via a structured approach to assist them in defining their SA/MH information needs and then matching these needs to appropriate websites. Websites will be cataloged in a database indexing ownership or authorship disclosure, purpose, standards met, language support, and user experience. The guide will also catalogue support for features other than content such as Q&A, bulletin boards, chat, news, MEDLINE searches, email lists, and screening forms. Users will be able to provide structured feedback on the listed sites to other health information seekers as well as to the website developer. The guide could be used to help developers of existing and future SA/MH websites enhance and improve their content. In Phase I we will create and evaluate a prototype site that indexes Internet resources on the topic of alcohol and alcoholism. Phase II will extend the site to a broad range of topics in substance abuse and mental health and evaluate the site's utility for both consumers and physicians. PROPOSED COMMERCIAL APPLICATION: As access to the Internet becomes more common increasing numbers of consumers and professionals are seeking health information on the Web. There are currently few means by which a health information seeker can quickly identify websites that meet his or her needs. The product of this research will be of value to on1ine advertisers as well as Internet portals interested in expanding the value of their service.